Investigating the role of gene regulatory networks in neonatal nutrition and immunity

PROJECT SUMMARY
The neonatal period of life is a critical time of rapid development. To fuel this growth, the neonatal
intestine must selectively absorb nutrients while establishing an immune defense against lumenal pathogens.
These two core functions are intimately linked, as impaired nutrition early in life impairs systemic immune
function. However, the connections between neonatal nutrient uptake and immune development remain poorly
understood. Unlike adults, neonates utilize a unique mode of nutrient absorption: macromolecules are absorbed
in bulk and subsequently degraded by lysosomes. Our lab has identified three transcription factors crucial to this
process: MAFB, cMAF, and BLIMP1. Deleting these genes from the intestinal epithelium prevents
macromolecular uptake, leading to neonatal malnutrition and lasting growth defects. Further, our preliminary
data indicate that the loss of these transcription factors restricts T cell infiltration in the neonatal intestine, and
leads to lasting defects in T cell localization in adults. However, the mechanisms through which MAFB, cMAF,
and BLIMP1 control neonatal nutrition and intestinal immune development remain poorly understood.
The long-term goal of this project is to elucidate the mechanisms that direct neonatal nutrition and
immunity, and determine the long-term functional consequences to organismal health. There is a pressing need
to understand nutrition-immune connections mechanistically, as undernutrition currently affects over 140 million
children globally and is implicated in almost half of pediatric mortality cases. To this end, the aims proposed in
this application will provide a mechanistic understanding of the role of MAFB, cMAF, and BLIMP1 in the neonatal
intestine. Aim 1 will leverage bioinformatic analysis combined with genetic mouse models to define the gene
regulatory networks controlled by these transcription factors, and how these networks control the function of
absorptive epithelial cells. Aim 2 will utilize loss-of-function mouse models to determine how MAFB, cMAF, and
BLIMP1 regulate the infiltration of diverse immune populations in the neonatal and adult intestine, and how these
transcription factors impact immune cell function and susceptibility to infection.
The proposed research will take place under the mentorship of Dr. Terry Lechler within the Duke
University School of Medicine. This environment will provide a network of collaborators and experts (both clinical
and basic science) in the fields of cell biology, developmental biology, and gastroenterology, that will provide
input and feedback as this project progresses. This project will also utilize multiple core facilities and shred
resource centers available on campus, in order to accelerate the progress of the proposed aims. The training
plan also includes attending scientific conferences annually to receive feedback from the broader field. Together,
the proposed project will reveal the molecular networks that control neonatal nutrition and immune development.
This work will provide mechanistic insight into a poorly understood yet critical stage of life, and will inform future
studies into the effects of neonatal malnutrition on human patients.

Public health relevance
PROJECT NARRATIVE Neonatal nutrition is critically important for organismal growth and immunity, as children who experience malnutrition have impaired immune development and increased risk of infection. Although the severe consequences of pediatric malnutrition are well-understood, the molecular mechanisms that control nutrient uptake in neonates is largely unknown. In this study, I will define the gene regulatory networks that control neonatal nutrient uptake, and determine how disrupting these transcriptional networks impacts intestinal immune infiltration and function.